Neuronal Adaptation and Plasticity after Chronic Disuse

ABSTRACT
Alzheimer's disease (AD) is a debilitating progressive neurodegenerative disorder affecting over 6 million
Americans. It is characterized by deficits in memory, which have been attributed to dysfunctional Hebbian
plasticity, a compelling synaptic mechanism supporting memory formation. Neurons also continuously adapt
their excitability and synaptic weights as response to network activity, harnessing homeostatic mechanisms to
preserve network stability and information flow. Our work on the parent NIMH R01 recently uncovered multiple
overlapping molecular players between Hebbian plasticity and synaptic homeostasis, providing a valuable clue
that homeostatic adaptation may also be disrupted in AD. It is therefore a natural extension of our main project
to explore how synaptic homeostasis is dysregulated in AD. Our preliminary findings demonstrate that synaptic
upscaling, a classical in vitro model of adaptation to chronic inactivity, is non-functional in neurons derived from
3xTg-AD mice. Under AIM 1, we will address the molecular players preventing synaptic upscaling in 3xTg-AD
by focusing on key signaling pathways uncovered by the parent R01 project. Mindful that gene transcription is
required for full development of synaptic homeostasis, we further discovered that transcriptomic changes
observed in wild-type (WT) neurons were largely absent in 3xTg-AD neurons. AIM 2 will therefore investigate
how this molecular program is disrupted, notably by attempting pharmacological interventions to rescue the
transcriptional program. We will use FK506 to block calcineurin and force biochemical events normally
recruited in the induction of synaptic upscaling. This will provide an avenue to probe where the defect in 3xTg-
AD neurons occurs. Finally, we have adopted a clinically-relevant, in vivo model of chronic activity, using
isoflurane as an exemplar of the volatile anesthetics used for surgery. This is experimentally useful because
isoflurane inhibits sodium channels, much like chronic TTX application, and clinically interesting because of the
oft-reported clinical association between general anesthesia and cognitive decline, particularly in the context of
AD. Under AIM 3, we discovered that while some transcriptomic changes are conserved across the main cell
types in the hippocampal formation, multiple dysregulated genes are observed in a cell type-specific manner.
Therefore, neuronal response to chronic inactivity needs to be understood in the context of cell type-specific
adaptations. Future experiments will strengthen the link between specific transcriptional changes and
homeostasis of neuronal activity or the lack thereof in 3xTg-AD animals. Furthermore, we will provide much
needed insight into the molecular underpinnings contributing to post-operative cognitive decline following
general anesthesia. Together, the proposed research will shed light on the mechanisms involved in the
dysfunctional homeostatic regulation of neuronal activity in a widely used model in AD. Understanding
underlying mechanisms and enabling their rescue will have powerful implications for development of
therapeutic approaches to AD.

Public health relevance
PROJECT NARRATIVE Defects in long-term memory and Hebbian plasticity have been abundantly documented in Alzheimer's Disease, yet homeostatic processes continuously adjusting neuronal properties as a function of network activity have been relatively overlooked. We find that synaptic homeostasis is dysregulated in an animal model of Alzheimer's Disease, prompting the study of how this phenomenon is impaired. Using both in vitro and clinically relevant in vivo models, we aim to uncover the mechanistic underpinnings of dysregulated synaptic homeostasis and their effect on neuronal networks in Alzheimer's Disease.